Membrane sphingomyelin and HSV entry

Herpes simplex virus (HSV) remains a major pathogen worldwide causing lifelong latent
infections in humans. It is responsible for significant disease, ranging from cold sores and
genital infections to blindness and fatal encephalitis. Herpesviral entry is a complex process
involving multiple viral and cellular factors. The long-term goal of this project is to understand
the molecular mechanisms that govern HSV entry into host cells. HSV particles are enveloped
in a host cell-derived lipid bilayer membrane. To accomplish entry, viruses must surmount the
barrier posed by the host membrane. Thus, the HSV entry process is intimately associated with
membrane interactions. The roles of lipid components of virus and cell membranes in HSV entry
are greatly understudied relative to membrane-associated proteins. Sphingomyelin (SM) is the
most common sphingolipid component of biological membranes and is a signature constituent
of lipid rafts. The specific role of SM in herpesviral entry is not well-understood. Based on our
published and preliminary data, two complementary specific aims are proposed. A battery of
assays will be employed to assess the importance of SM for specific steps in the entry process
including cell attachment, endocytic uptake, intracellular vesicular transport, and membrane
fusion. In Specific Aim # 1, we will elucidate the function of HSV envelope sphingomyelin in viral
entry. Experiments in Specific Aim #2 follow from preliminary data indicating the selective
importance of host cell SM in HSV entry by an endocytosis pathway. The precise step(s) in the
entry cascade that require cellular SM will be defined. A combination of molecular, biochemical,
and cell biological approaches will be used to fill key gaps in our understanding of HSV entry.

Public health relevance
Herpes simplex viruses cause cold sores and sexually transmitted infections, and can also cause the serious complications of neonatal infections, blindness, and fatal encephalitis. The purpose of this research is to determine how the herpes simplex virus initiates infection in humans by studying the virus interaction with host cell lipids. Greater understanding of the virus entry process will help to identify novel approaches to prevent herpes infections.